SCAR 2025: Stronger Together

Severe cutaneous adverse reactions (SCAR), including both Stevens–Johnson syndrome/toxic
epidermal necrolysis (SJS/TEN) and drug reaction with eosinophilia and systemic symptoms (DRESS),
are immunologically-mediated, life-threatening, and typically drug-induced diseases affecting adults
and children that result in significant morbidity and mortality. Survivors of SCAR are often left with long
term-disabilities that can affect their quality of life and a lifelong fear of taking any new, even if unrelated,
drugs. SCAR reactions are often associated with drugs used to treat diseases of public health
importance globally such as tuberculosis and leprosy. Even though SCAR is rare, it is often severe and
requires effective care across different populations globally, including highly coordinated teams of
multiple disciplines that are comprised of dermatologists, critical care specialists, ophthalmologists,
allergists and immunologists, pharmacologists, infectious diseases, and mental health specialists. For
the first time, and to further the success of our DRESS 2022 meeting and previously NIH-funded
SJS/TEN meetings in 2017, 2019, 2021, and 2023, we are proposing to hold “SCAR 2026: Stronger
together,” a joint meeting planned for 2026. SCAR 2026 will be in-person to catalyze progress in
improving prevention, early diagnosis, and treatment of SCAR. The scheduled 2.5-day meeting will
include plenary and patient and community-focused sessions on the first day, followed by keynote and
scientific breakout sessions the subsequent two days. Topics covered will be both overlapping and
distinct to individual SCAR. Community engagement will once again be a key theme of the meeting.
“SCAR 2026” will showcase new science from both diseases in addition to understanding and
translating knowledge within and between diseases. The meeting will again provide a rich training
environment of networking and interactions for early investigators. We will focus on understanding
SCAR mechanism (both shared and separate) through research and continue our community and
patient-focused sessions to bring the patient voice into all of these important discussions.

Public health relevance
Narrative Stevens-Johnson Syndrome/toxic epidermal necrolysis (SJS/TEN) and drug reaction with eosinophilia and systemic symptoms (DRESS) are among several severe cutaneous drug reactions (SCAR) that are associated with significant morbidity and mortality. Even with the severity of these diseases, there is no standing organized forum to foster focused networking, mentorship of early career and established scientists, cross – disciplinary research and community engagement. For the first time, and further to the success of the DRESS 2022 meeting and previously NIH funded SJS/TEN 2017, 2019, 2021 and 2023 meetings, we are joining forces to build “SCAR 2025 – Stronger Together”, a joint meeting to cover all severe cutaneous adverse drug reactions (SCAR) including SJS/TEN and DRESS with the goal of improving the prevention and treatment of these severe diseases.